Epigenetic Profiling of circulating cell-free DNA for the Monitoring of Graft-Versus-Host Disease after Hematopoietic Cell Transplantation

Allogeneic Hematopoietic Cell Transplantation (HCT) is a widely used therapy for a variety of malignant and
nonmalignant hematologic diseases. More than 8,500 patients, receive HCT transplants in the US each year.
Yet, up to 50% of patients suffer complications due to graft-versus-host disease (GVHD) in the first year after
HCT. GVHD occurs when donor immune cells attack the patient’s own tissues. GVHD can occur anywhere, with
the skin, gut and liver most frequently affected. GVHD remains one of the major barriers to a more widespread
application of allogeneic HCT.
Early diagnosis of aGVHD is critical to inform treatment decisions and prevent serious organ injury and death.
Unfortunately, few informative diagnostic approaches are available. In current clinical practice, diagnosis of
aGVHD relies almost entirely on the presence of clinical symptoms and requires confirmation via invasive biopsy
procedures, such as skin biopsy, colonoscopy, upper endoscopy or liver biopsy. HCT patients urgently need a
better alternative.
The goal of this proposal is to develop and apply a blood test to detect acute GVHD (aGVHD) and to
predict long-term HCT outcomes. This test employs genome-wide profiling of methylation marks comprised
within circulating cell-free DNA (cfDNA) in blood to trace their tissues-of-origin, and to quantify tissue-specific
injury after HCT. This concept is supported by significant pilot data.
We will perform a retrospective study of the utility of cfDNA to stratify HCT recipients with single organ aGVHD
(Aim 1), and a prospective study of the utility of cfDNA to detect the early onset of GVHD and to predict HCT
risk (Aim 2). Together these aims explore the highly innovative concept that a measurement of the tissues-of-
origin of cfDNA in plasma enables to i) detect aGVHD, ii) quantify the severity of aGVHD and determine its organ
involvement, iii) predict post-HCT mortality, and iv) predict the outcome of aGVHD treatments.
This proposal directly addresses an urgent, unmet medical need: the early and noninvasive diagnosis of aGVHD
after HCT. These studies are therefore highly translational. A highly informative, noninvasive monitoring tool may
inform new treatment modalities and transplant strategies. Recognizing the limitations of universal prophylactic
therapy against aGVHD, cfDNA assays could find future use in guiding pre-emptive treatment strategies, thereby
reducing the need for prolonged immunosuppressive therapy after transplant. Furthermore, earlier detection of
aGVHD could lead to shorter durations of therapeutic immunosuppression and improved patient outcomes.

Public health relevance
Allogeneic Hematopoietic Cell Transplantation (HCT) is a life-saving therapy for the treatment of blood cancers and immune disorders, but complications due to graft-versus-host disease (GVHD), an immune response that can affect any organ, limit the long-term benefits of HCT. This proposal explores the highly translational concept that a measurement of the tissues-of-origin of cell-free DNA in the blood circulation enables to detect GVHD and its organ involvement and can predict long-term outcomes of HCT. Successful implementation of these studies will lead to a blood test for the monitoring of GVHD after HCT, which will represent a critical advance in HCT that can lead to better strategies to prevent GVHD and better treatments.